Project 4: Care Integration for Patients with Cancer Using Specialty Pharmacies

PROJECT SUMMARY/ABSTRACT: Project 4 -
This project aims to examine the integration of specialty pharmacies into systems/hospitals and independent practices and its impact on patients’ use of and adherence to orally-administered anticancer and supportive care drugs. Health care systems and independent practices have increasingly opened their own specialty pharmacies or are increasingly contracting with off-site contract pharmacy services—forms of structural integration. Alternatively, health systems or practices may work with specialty pharmacies that are completely independent. This Project will examine the extent to which pharmacy services are integrated into practices (in the presence and absence of structural integration) and the role of specialty pharmacies in working with oncologists and patients to ensure that patients can access, initiate, and adhere to prescribed oral anticancer medications and supportive care medications. This Project also will work closely with Project 1 to consider the impact of hospital 340B discounts on structural integration as systems open on-site pharmacies or contract with off-site pharmacy services. Working with Projects 1, 2, and 3 and the Cores, the team will conduct case studies to adapt an existing conceptual framework of integration to oncology care relevant to this setting. The team will survey leaders, managers, clinicians, and staff in systems, practices, and specialty pharmacies (including in-house and independent specialty pharmacies). The team will use Medicare administrative data to describe key outcomes, including the proportion of patients filling oral anticancer drugs, time from visit to orally-administered anticancer medication fill among those who initiate treatment, and medication adherence among those who initiate treatment. We will assess the association of various forms of integration on these outcomes. The aims mirror the overall Project aims:
Aim 1: Adapt an existing conceptual framework to describe key forms of integration (i.e., structural, functional, normative, interpersonal, process) for pharmacy services for patients with cancer who may benefit from oral anticancer medications. Identify mechanisms through which forms of care integration may produce better care and outcomes.
Aim 2: Measure care integration in practice sites and specialty pharmacies and assess relationships among different forms of integration. Determine if and how integration varies by practice characteristics (e.g., 340B discounts, proportion of patients in rural areas) and market factors (e.g., competition, payer mix).
Aim 3. Assess the association of practice and specialty pharmacy integration with medication use outcomes and assess mechanisms through which integration improves or worsens care and outcomes overall and for patient subgroups, such as low-income patients and those living in rural areas.
Assessing the association between specialty pharmacy integration and patient medication use outcomes will inform policies and practices that improve patient care and outcomes.

Public health relevance
PROJECT NARRATIVE: Project 4 - This Project will examine the extent to which pharmacy services are integrated into practices (in the presence and absence of structural integration) and the role of specialty pharmacies in working with oncologists and patients to ensure that patients can access initiate and adhere to prescribed oral anticancer medications and supportive care medications. The findings will inform specialty pharmacy leaders oncology practice leaders and policy makers about strategies to facilitate care integration to improve care delivery for patients with cancer who may benefit from oral anticancer and supportive care medications.